Translational Research Support Core

TRANSLATIONAL RESEARCH SUPPORT CORE (TRSC): ABSTRACT
The Translational Research Support Core (TRSC) is the single entity that enables CEET to
perform translational environmental health research that impacts individuals and communities. In
the transition from an Integrative Health Sciences Facility Core (IHSFC) to the TRSC, we have
renewed our focus to support translational science, as conceptualized by NIEHS, among CEET
basic scientists, clinical researchers, community engagement experts, and public health
practitioners. In alignment with the NIEHS framework for translational research, the TRSC mission
is to accelerate research in environmental health sciences leading to improvements in
clinical and population health outcomes. To achieve this mission, the TRSC will provide
infrastructure to (1) support the translation of basic science observations that relate environmental
exposures to adverse outcomes into human studies that detect, prevent and/or manage diseases
induced or exacerbated by these exposures and (2) translate findings from human studies to
approaches that can be implemented to improve public health. A major focus of this core is to
predict who is at risk of exposure, who is at risk for disease, and the identification of predictive
and prognostic biomarkers. The TRSC interfaces with the Community Engagement Core (CEC)
to enhance the partnership between CEET investigators and community-based organizations to
identify community concerns and develop research questions so that CEC can ultimately
implement and disseminate findings of CEET investigators back to local, national, and global
communities. Community-based questions relating to healthy individuals or patients are
communicated by the CEC and framed into scientifically relevant questions by the TRSC for
CEET investigators to address. Services provided by the TRSC to CEET investigators include:
(a) Human Study Design and Implementation Science Services, (b) Environmental Exposure
Services, (c) Preclinical and Human Exposure Laboratories, (d) Population-based Cohorts and
CEET Biorepository resources, and (e) Training Opportunities in Translational Research. The
TRSC will work collaboratively with the Environmental Health Informatics Core (EHIC) and the
Biomolecular Mass Spectrometry Core (BMSC), to provide comprehensive support of research
across our Thematic Areas and in the cross-cutting themes of exposomics and the effects of
extreme weather on health, as well as partner with investigators, CEC members and communitybased
organizations to impact clinical practice and public health research. The TRSC will lead
the development of studies across the Center’s Thematic Areas that focus on the translation of
mechanistic findings to investigations in humans to advance exposure measurement, risk
assessment, and develop and test interventions that will impact prevention and treatment
strategies.